Preteen Suicide Risk and Protective Factors Data Coordinating Center

PROJECT SUMMARY/ABSTRACT
Suicide is a leading cause of death in youth ages 8–12 years, and rates of suicide in children
are increasing. Alarmingly, suicide increased 87% in ages 10–14 from 2000 to 2021 and 49% in
those ages 15–24. The National Institute of Mental Health (NIMH) will support a Consortium of
six research projects and a data coordinating center (DCC) to improve understanding of risk and
protective factors related to preteen suicidal thoughts and behaviors for a range of youth. We
recognize that this important and complex endeavor requires exceptional coordination across a
range of activities inherent to a multi-site Consortium as well as expertise in data harmonization,
integration, and a multidisciplinary lens. RTI proposes to serve as the DCC for this Consortium
of investigators. In this capacity, RTI will facilitate data coordination by assisting the Consortium
in developing common measures and metrics and in establishing common data formats, data
structure, and data-sharing processes (Aim 1). RTI will also facilitate scheduled data monitoring
and analysis as well as dissemination of Consortium results (Aim 2). RTI will promote research
efficiency and foster collaboration by establishing a centralized structure for scientific,
administrative, and logistical operations (Aim 3). Finally, RTI will maximize the scientific impact
of Consortium data by facilitating data sharing and developing best practice guidelines to
optimize use of the data by the broader scientific community (Aim 4). Our DCC team will be led
by a developmental psychopathologist with extensive data coordination experience and data
integration and harmonization science. The broader team will comprise experienced leaders of
multi-site studies and experts in consensus building, data harmonization, and preteen suicidal
thoughts and behaviors for this age group. Core leaders, key staff, and consultants will bring
robust data harmonization and data science approaches interwoven with a deep understanding
of preteen suicide and suicide multidisciplinary science. We offer proven computational
infrastructure and statistical expertise to support all the required data management and analysis
needs for the Consortium. RTI will back this project with its unsurpassed experience and
proficiency—born from successful leadership of over 40 other coordinating centers—to support
and accomplish these aims. Collectively, we are well prepared to help NIMH and the
Consortium to produce data and best practices for the research community studying preteen
suicide risk and protective factors across developmental trajectories that are sensitive to all
youth, including those in underrepresented and under-resourced contexts.

Public health relevance
PROJECT NARRATIVE The Preteen Suicide Risk and Protective Factors Data Coordinating Center (DCC) will work with six research projects to agree on and publish common data elements designed to help researchers identify factors that put children ages 8–12 at risk for suicidal thoughts and behaviors. The DCC will help coordinate information produced by these research projects to make data available for other researchers through the National Institute for Mental Health Data Archive.